A Novel Mobile Health Exercise Intervention in Aging: Brain Perfusion and Cognition

PROJECT SUMMARY/ABSTRACT
Research efforts focusing on maintaining brain and cognitive health in aging have become a critical public
health concern given that the number of people over 65 will increase from 40.2 million in 2010 to 88.5 million
by 2050 in the United States, with a forecasted AD prevalence of 13.8 million. It is crucial for health
professionals to develop behavioral interventions that prevent cognitive decline in healthy older adults.
Cardiovascular risk factors have been associated with cognitive decline, and cerebrovascular changes are very
common in normal aging, suggesting that targeting cardiovascular risk factors could potentially help to maintain
cerebrovascular and cognitive health. Physical activity interventions conducted in supervised settings
(laboratories and group settings) with older adults have consistently shown improved cardiovascular and
cerebrovascular health and improved cognitive function. What is lacking is the development of interventions
that take place in real world environments and that take advantage of new technologies to help objectively
track real time physical activity behaviors. Real world physical activity interventions have the potential to reach
a larger segment of the population and to enhance maintenance after the intervention period ends. The
proposed research project will develop a novel, 6-month physical activity intervention using mobile health
technologies to promote physical activity levels likely to affect cerebral blood flow and cognition in real world
environments in cognitively normal older adults aged 65-75. The goal of this intervention is to increase time
spent in moderate to vigorous physical activity to 150 min/week, which is recommended by the American Heart
Association for cardiovascular benefits. For this purpose, a randomized controlled trial will be conducted with
30 participants being assigned to the mobile health physical activity condition and another 30 to an education
control condition for 6 months. Physical activity prescriptions will target 60-75% of each individual’s maximum
heart rate based on fitness testing and will be conducted independently in real world environments. Moreover,
we will investigate if this novel intervention has the potential to increase cerebral blood flow and improve
cognition as has been shown by previous research in controlled environments. This five year K23 application is
designed to provide the applicant with the necessary training to become an independent clinical scientist
focusing on developing behavioral interventions to improve brain and cognitive aging. This project builds on the
applicant’s previous experience with cognitive neuroscience of aging, brain imaging, and neuropsychology to
achieve the following training goals: 1) Obtain extensive training in the development and implementation of
physical activity interventions with older adults using mobile health technology; 2) learn how to collect, process
and analyze cerebral blood flow and resting state connectivity brain imaging data ; 3) develop expertise in the
design and implementation of randomized controlled trials (including advanced statistics); and 4) obtain
experience with scientific writing and grantsmanship. Completion of this project and associated training goals
will ensure the applicant obtains the necessary skills and experience to transition into the role of an
independent investigator who integrates the fields of exercise science, real world behavioral interventions,
cognitive enhancement, and brain imaging with older adult populations.

Public health relevance
PROJECT NARRATIVE Physical activity interventions with older adults can improve brain health; however most interventions have been performed in gym-like settings that reach a small sector of the senior population. Since not everyone can access a gym, it is important to study whether brisk walking in real world environments can also help brain health. This study will use mobile health devices to help older adults independently walk for brain health, thus representing a critical step towards the dissemination of physical activity intervention programs aimed at preserving cognitive function in aging.